Real-time imaging of opioid neuromodulation with novel genetically encoded fluorescent sensors

PROJECT SUMMARY/ABSTRACT
Opioids are the most widely used analgesics for chronic pain and post-operative care. However, opioid misuse
has resulted in a national overdose crisis fueled by untreated opioid use disorder (OUD) and the infiltration of
the potent synthetic opioid, fentanyl, into the drug supply. Fentanyl primarily signals at the µ-opioid receptor
(µOR), a G protein-coupled receptor (GPCR) expressed throughout many subcortical brain regions responsible
for regulating pain perception, reward, stress, and emotion. However, the pharmacological and
spatiotemporal profile of fentanyl in the brain is currently poorly understood. Traditional tools to monitor
opioid distribution lack specificity and spatiotemporal resolution. Previously, the Berndt Lab developed a
fluorescent opioid sensor, μMASS, which couples real-time opioid detection at the µOR to an increased
fluorescence response. However, like the µOR, μMASS detects a variety of opioids, including endogenous met-
enkephalin and exogenous fentanyl, making it difficult to discern signals between specific ligands. My goal is to
engineer a fentanyl-specific fluorescent opioid sensor to investigate fentanyl pharmacology and
pharmacokinetics in real-time. Previously, I combined AI-guided structure determination and molecular
docking to study µMASS-fentanyl binding in silico, and observed µMASS did not maintain a critical salt bridge
with amino acid D1473.32. Mutating this residue to a glutamate (D1473.32E) rendered the sensor specific only for
fentanyl, which I dubbed FentMASS1.0. To engineer a next-generation fentanyl sensor with enhanced sensitivity,
specificity, and expression, in Aim 1.1 I will bolster my current approach using updated structure prediction
models and molecular dynamics simulations to observe sensor-fentanyl interactions and identify new mutation
targets. In Aim 1.2 improved sensor variants will be rapidly generated and screened using a high-throughput
protein engineering approach established in the Berndt Lab and optimized for neuronal expression in Aim 1.3.
Finally, in Aim 2 I will validate the optimized fentanyl sensor (or FentMASS1.0) in µOR-expressing brain regions
in ex vivo brain slices and determine fentanyl pharmacology in real-time. In the end I will have an enhanced
µOR-based fentanyl sensor with optimized expression in neuronal tissue, which can then be applied to study
fentanyl pharmokinetics across brain regions in vivo in freely behaving animals. This proposal is significant
because there is currently no available µOR-based sensor to study fentanyl pharmacology with reliable
sensitivity, kinetics, and neuronal expression. The approach is innovative as it combines AI-guided structure
determination and in silico molecular modeling in combination with next-generation high-throughput sensor
engineering techniques to rapidly optimize a GPCR-based sensor. This approach and resulting sensor
technology will aid in studies to characterize the progression of fentanyl induced OUD while laying the
groundwork for developing future specific opioid sensors.

Public health relevance
PROJECT NARRATIVE Opioid overdose is a critical challenge to public health and is worsening due to widespread fentanyl use and untreated opioid use disorder (OUD). To help combat this epidemic, we require tools to determine fentanyl pharmacology and pharmokinetics in real-time. This proposal aims to develop an optimized genetically encoded fluorescent fentanyl sensor with validation in µOR-expressing brain tissue to pave the way for real-time fentanyl detection across opioidergic brain regions in freely behaving animals.